Traineeships in AIDS Prevention Studies

ABSTRACT
Training the next generation of HIV prevention scientists, skilled in the methods of multiple fields, and
increasing the number of under-represented minority researchers are the long-term goals of the postdoctoral
Traineeships in AIDS Prevention Studies (TAPS) at UCSF. Our goals are to build the skills of postdoctoral
fellows to engage in research that: 1) combines biomedical, behavioral, social and structural interventions to
maximize impact, 2) eliminates racial/ethnic disparities in HIV in the US, and 3) develops novel prevention
interventions. TAPS balances the behavioral and biomedical sides of prevention by training scientists newly
minted in their respective fields in the disciplines of their co-postdoctoral fellows. TAPS is housed in UCSF’s
Center for AIDS Prevention Studies (CAPS) within the Division of Prevention Science, with close relationships
to other institutions within the AIDS Research Institute (ARI) umbrella. The program requires one-on-one
mentorship with senior faculty; a master’s degree in clinical or public health research; advanced courses in
research methods and ethics; seminars and grand rounds; peer review and teaching; designing, grant writing,
and implementing research projects; and submission of papers for publication. Since inception, TAPS has
trained 132 fellows. Our recruitment has more than doubled from a cumulative proportion of 22% under-
represented minorities (URM) in 2003-2007 to 50% for the last 15 year period (2008-2023). We also achieved
100% retention of URM in research. Alumni in the last 10 years produced 704 publications, including 267
(38%) as first author, mean=19.6 papers/trainee. In addition, they were awarded 86 research grants, 68 (79%)
they served as Principal Investigator (PI). Five-year renewal of TAPS will permit training of 1 - 3 new fellows
per year who we envision will be poised to lead the charge to Ending the HIV Epidemic and carry on to
address major future health issues in the US and worldwide.

Public health relevance
PROJECT NARRATIVE The goals of our postdoctoral training program (Traineeships in AIDS Prevention Studies, or TAPS) are to train the next generation of HIV prevention scientists who will be skilled in diverse research methods, and to increase the number of ethnic/racial minority researchers; and thus we seek to build the skills of postdoctoral fellows to engage in research that combines biomedical, behavioral, social and structural interventions to have the biggest impact on the HIV epidemic and to train more ethnic/racial minority scientists. TAPS balances social/behavioral and biomedical/clinical sides of prevention and is housed in UCSF’s Center for AIDS Prevention Studies (CAPS) within the Division of Prevention Science, with close relationships to other institutions working in HIV prevention. Since the start of TAPS, we have trained 132 fellows who have become leaders in the field and this five-year renewal will permit training of 2-3 new fellows per year, for a total of 6 in the program.